Core A: Administrative Core

Project Summary/Abstract
The SPORE has the overall goal to improve cancer health outcomes by investigating the interplay of genomic and immune characteristics with individual risk factors and external factors. Three cancers (meningioma, prostate cancer and breast cancer) with well-known differences as it relates to clinical outcomes in various patient populations, will be studied. The emphasis will be to provide a better understanding of the specific biological mechanisms in relation to individual risk factors and external factors and to ultimately translate this knowledge into improved patient outcomes. The projects will be supported by 2 specialized Cores with expertise that complement not only the function of the cores, but also the specific cancer specific biology. In addition to leveraging the multidisciplinary expertise within the research programs in the UCSF Helen Diller Family Comprehensive Cancer Center and the incredible resources from the institution, this SPORE will benefit greatly from rich collaborations with investigators at outside institutions and the Community Advisory Board members. The goal of the Administrative Core is to supervise the activities of the UCSF SPORE to ensure the success of the research conducted across the components within the SPORE. The core will provide fiscal management, administrative support, and the framework by which researchers can communicate and interact to achieve their research goals. The specific aims of the SPORE Administrative Core are: 1) To provide administrative support through the coordination of monthly team meetings and the annual scientific advisory board retreat. The Core will also work with the investigators to prepare the yearly progress reports and SPORE-related manuscripts. 2) To evaluate research progress and oversee the effective utilization of core resources across the projects to successfully conduct the aims 3) To provide fiscal management through timely distribution and budgetary reporting to all leaders of the components of the SPORE as well as the DRP/CEP awardees, and subcontracts at other institutions. 4) To assist in compliance by ensuring the regulatory compliance and scientific integrity, including biostatistical considerations, of the relevant components of the SPORE. 5) To facilitate communication among SPORE investigators and between the SPORE and outside entities including the NIH. The Administrative Core will serve all Projects, Programs, and Cores in the SPORE.